Task 7: Toxiciology Testing for TB Therapeutics

This task provides toxicology testing for a tuberculosis therapeutic under the NIAID Preclinical Services for the Development of Interventional Agents Program.